Short inhibitory RNAs in platelet and megakaryocyte function

Project Summary The goals of this proposal are: 1) to investigate siRNA-mediated in vivo knockdown of
megakaryocyte (MK) / platelet P2y12 as antithrombotic with improved hemostatic protection compared to drug
blockade; 2) to investigate siRNA-mediated in vivo knockdown of MK / platelet negative regulators IP (PGI2
receptor) and Gαs in platelet function and hemostasis; 3) to determine the mechanistic basis for selective
uptake and utilization of naked double-stranded (ds) small non-coding (nc) RNAs by MK / platelets ex vivo and
in vivo. We have shown for the first time that platelets and MK can be transfected in vivo, selectively and at
high efficiency, by intravenous or subdermal administration of naked (unencapsulated, unconjugated) ds short
inhibitory RNAs (siRNAs), resulting in suppression of target gene expression and altered gene-dependent
functions restricted to platelets and MK. The unique ability of MK and platelets to internalize and utilize naked
ds ncRNAs - without encapsulation in liposomes or other nanoparticle structures that eliminate tissue targeting
specificity, and without covalent targeting moieties that greatly reduce silencing efficiency – provides the
opportunity both to study and to manipulate gene expression specifically in MK and platelets. Thus, we have
established a highly novel, tractable system of MK and platelet reprogramming in vivo by gene silencing
selectively in the MK / platelet lineage. This proposal aims both to exploit, and to study, this tissue-selective
siRNA-mediated gene knockdown approach. In Aim 1 we will focus on siRNA-mediated in vivo knockdown of
P2y12, the primary purinergic (ADP) receptor on platelets that is the molecular target of current frontline
antiplatelets such as clopidogrel, cangrelor and ticagrelor. While these drugs can be effective antithrombotics,
they are also associated with risk of clinical bleeding ranging from moderate to severe including intracranial
hemorrhage, as a result of total pharmacological blockade of P2y12 that compromises hemostasis. We will test
the hypothesis that reduced P2y12 expression by in vivo knockdown is sufficient to modulate thrombosis
without compromising hemostasis. We will further exploit this approach to investigate P2y12 expression during
MK / platelet development. In Aim 2 we will employ in vivo platelet-selective siRNA transfection to investigate
the roles of the IP and Gαs pathways in platelet reactivity and hemostasis. In both Aims 1 and 2, we will
investigate the hypothesis that dynamic control of expression of these key regulatory proteins across the
circulating platelet lifespan contributes essentially to diversity in platelet function among the population, with
important functional outcomes. This hypothesis represents a novel fundamental aspect of platelet molecular
physiology with strong potential impact. In Aim 3 we will investigate the hypothesis that the unique uptake and
utilization mechanisms of naked mi/siRNAs by MK and platelets derive from specialized fluid-phase
endocytosis. Together, these studies will elucidate several related pathways highly relevant to platelet
physiology and disease, and will form the basis for pre-clinical development of novel antiplatelet therapeutics.

Public health relevance
Project Narrative We have established for the first time a highly novel system of non-integrative, temporally controlled, tunable gene therapeutic reprogramming of blood platelets and their parent cells, megakaryocytes, by targeted suppression of protein translation from individual mRNAs in vivo, which we have found is naturally selective for the megakaryocyte / platelet lineage without affecting other cell types. This proposal aims both to exploit, and to study, this tissue-selective gene therapeutic approach. The studies in this proposal will employ this cutting edge approach to elucidate the cellular and physiological roles and underlying mechanisms of several related pathways highly relevant to platelet physiology and disease, and to study the unique properties of platelets and megakaryocytes that support this tissue-specific gene therapeutic reprogramming.